Molecular and cellular mechanisms of HSV-1 assembly and egress

Project Summary/Abstract
Alpha herpesviruses, including the important human pathogen Herpes Simplex Virus 1 (HSV-1), are
among the very few viruses that have evolved to exploit highly-specialized neuronal cell biology. During the
natural course of disease, alpha herpesviruses infect peripheral nervous system (PNS) ganglia, persist as a
life-long latent infection, and occasionally reactivate to cause recurrent lesions in peripheral tissues, or can
spread to infect the central nervous system. Upon reactivation, replication, and assembly, progeny virus
particles can exit from the soma/dendrites of infected neurons, or can sort into axons and undergo long-
distance axonal transport. HSV-1, in particular, is a leading cause of viral encephalitis, and may also contribute
to the development of neurodegenerative disease.
The main objective of this supplement proposal is to determine the microtubule motor-based
mechanisms that mediate axonal sorting, specifically in PNS neurons. In Aim 1, we will determine the roles of
different kinesin motors and microtubule-associated proteins in intracellular transport of progeny virus particles
in non-neuronal cells by live-cell imaging. In Aim 2, we will determine the roles of these motors and
microtubule-associated proteins in axonal sorting in primary neurons, using a microfluidics-like chambered
neuronal culture system. In this supplement application, the proposed experiments are novel, but are within the
scope of the parent R01 award.
Elucidating the basic cell biological processes that our viruses use in both neurons and non-neuronal
cells will increase our understanding of how and why herpesviruses spread to and within the nervous system,
lead to the identification of druggable targets and development of better therapies for viral neuropathology, and
may provide fundamental insights into cell biology, particularly of the cell biology of neurons.

Public health relevance
Project Narrative Alpha herpesviruses, like herpes simplex virus 1 (HSV-1), naturally infect the peripheral nervous system causing recurrent herpetic lesions, and can spread to the central nervous system causing encephalitis or may contribute to neurodegenerative disease. To spread in the nervous system, alpha herpesviruses must transport inside and then exit from infected neurons, at or near neuronal synapses. The goal of this research is to better understand how HSV-1 spreads in the nervous system by investigating the molecular and cell biology of these processes.